The genetic basis of emerging multidrug resistance in Plasmodium falciparum African malaria

PROJECT SUMMARY
Efforts to effectively treat and control Plasmodium falciparum malaria in Africa now face the critical issue that
parasites in East African countries have acquired resistance to artemisinin (ART), the core component of the
primary first-line therapy combination therapy of artemether plus lumefantrine (LUM) known as Coartem. Recent
studies have observed the rapidly increasing prevalence of K13 mutations (C469Y, R561H, R622I and A675V)
in isolates from Uganda, Rwanda and Ethiopia, which associate with in vitro and in vivo ART resistance. Gene
editing studies have shown that K13 mutations alone are generally insufficient to mediate ART resistance in
African parasites, and alternative pathways to resistance are likely. Recent reports have also observed reduced
susceptibility to LUM in Northern Uganda, which may signal the impending loss of Coartem treatment efficacy in
this region that may well spread across Africa. Our study is designed to elucidate the genetic basis of emerging
multidrug resistance in Uganda and evaluate how resistance mediators can affect parasite proliferation and
transmission potential, as these factors govern the spread of ART resistance in high-transmission settings
frequently found in Africa. Our first aim is to study k13-mediated and k13-independent ART resistance in
Ugandan parasites, which will provide insight into the complex genetic architecture and elucidate alternate
mediators of resistance. We will achieve this by implementing two genetic crosses using the humanized FRG-
NOD mouse model. Our first cross will be between an ART-resistant K13 mutant Ugandan isolate and the drug-
sensitive NF54 African line to elucidate secondary genetic modulators that interact with k13 to generate
resistance. Our second cross will employ an ART-resistant K13 wild-type Ugandan isolate crossed with NF54 to
identify markers for ART resistance that evolved independently of k13. We will establish phenotypic and genomic
profiles of recombinant progeny and apply quantitative trait loci (QTL) mapping to locate primary and secondary
determinants of ART resistance, confirm causal and secondary determinants using gene editing, and examine
their epistatic interactions. Our second aim is to understand the genetic basis of decreased LUM sensitivity in
Northern Uganda by exploiting the second cross, whose Ugandan parent displays high LUM IC50 values. Our
complementary genetic mapping approaches of applying bulk segregant analyses of recombinant pools coupled
with clone-based QTL mapping will identify candidate markers that we will validate using reverse genetics. Our
third aim is to study the impact of Ugandan K13 mutations and other resistance markers on parasite growth and
transmission to Anopheles vectors, and identify mutations that compensate for fitness defects in drug-resistant
lines. This will be achieved by measuring fitness using competitive growth mixed-culture assays and bulk
segregant analyses, and quantifying mosquito infectivity of edited mutant and wild-type isogenic lines. Our
findings will provide robust molecular markers to track and inform efforts to mitigate emerging multidrug
resistance in Africa and delineate the relationship between drug resistance, parasite fitness and transmission.

Public health relevance
PROJECT NARRATIVE This research will implement and characterize genetic crosses to identify key molecular determinants associated with artemisinin resistance and reduced lumefantrine susceptibility in African Plasmodium falciparum malaria parasites and characterize the impact of these mutations on parasite fitness and transmission. The results will provide robust molecular markers that can be used for molecular surveillance of parasites resistant to this first- line drug in Africa, where the disease burden is by far the greatest in the world. Our findings will help guide strategies to protect artemisinin-based combination therapies, impede the spread and establishment of multidrug resistance, and inform strategies to design more effective antimalarial drug treatments aimed at reducing malaria’s massive impact on global health.